Training Program in Translational Vision Sciences

Project Summary/Abstract
Translating basic vision research to the clinic progresses at an astounding rate, but we still have a long way to
go in developing treatments and potential cures for blinding vision diseases. The advancements in methods,
e.g., viral vectors, genetic approaches, single cell transcriptomics, imaging modalities, optogenetics, and stem
cell-based approaches, have changed our ability to understand the visual system in health and disease. The
major aim of the University of Minnesota’s program in the Training in Translational Vision Sciences is to prepare
predoctoral trainees for careers as independent scientists with excellent knowledge of basic science, and
importantly, provide connections to clinical problems and real patients with vision-threatening disorders. The 18
training faculty are a well-funded, productive group of vision scientists with a commitment to training the next
generation of vision scientists. Ten of these 18 have funding from the National Eye Institute, but all preceptors
have well-funded laboratories and strong publication records. The major areas of research focus include real-
time imaging, visual processing in human and animal models, vascular biology, and development. These focus
areas are typically coupled with a strong translational objective focused on developing new strategies to improve
vision in individuals with significant visual impairment. We are requesting funding to support five predoctoral
candidates who have entered into the laboratories of one of the vision scientist preceptors. Predoctoral trainees
will come from one of four graduate programs: “Neuroscience”, “Molecular, Cellular, Developmental Biology &
Genetics”, or “Biochemistry, Molecular Biology, and Biophysics” in the medical school, or the Graduate Program
in Psychology in the College of Liberal Arts. With the focus on translational vision science, we have greatly
increased the collaborations between basic scientists and the clinical faculty in the Department of Ophthalmology
and Visual Neurosciences (DOVN). Several new key elements of the Translational Vision Research Training
program include a newly designed course for trainees, Critical and Translational Reasoning in Visual Science,
co-taught by the training faculty and the clinical faculty in the DOVN. All trainees must attend and present their
research at our annual Spring Symposium, where nationally known and in-house experts in vision science
present their most recent research along with our trainees and faculty as well as participate in one of several
vision-related journal clubs. The Program Directors and Executive Committee select and evaluate trainees for
this program. The program directors are Linda McLoon PhD and Harald Junge PhD, both in the DOVN. We have
built in a Program Director transition plan, with Drs. McLoon and Junge sharing the position during the first two
years of the program, and with Dr. Junge taking over as Principal Investigator in years three to five. As we move
toward increasingly collaborative research between our basic and clinically trained faculty members, the training
we provide will maximize our ability to prepare vision scientists with a multi-disciplinary education needed to
meet the “audacious goals” of the NEI - focused on preventing, treating, and rehabilitating blinding eye disease.

Public health relevance
Project Narrative Vision impairment affects over 4 million Americans over the age of 40, at a direct cost of over $140 billion dollars per year, producing a critical need to train the next generation of vision scientists to work in areas of translational vision science. Our goal is to train vision scientists who understand the need for translation of their discoveries in the laboratory to clinical treatment and rehabilitation strategies, armed with an understanding of the biology and pathophysiology of vision disorders that will facilitate development of therapies and potential cures to blinding and vision impairing diseases. As faculty with significant translational components to our work and with processes in place to aid in this training, we are well positioned to train these future translational vision scientists.